The role of cultural risk and resiliency factors and the built neighborhood environment on maternal depressive symptoms in pregnant Mexican-American women

Document not required per FOA or Workspace, but because “Application” is selected on the SF 424 R&R, grants.gov system thinks it is needed for submission. Grants.gov ticket number inquiry 850729.

Public health relevance
Project Narrative The Mexican-American population is the most rapidly growing group in the US and young children are at risk for developing emotional and behavioral problems which may be driven by prenatal exposure to elevated levels of stress and depression that Mexican-American women experience during pregnancy. The proposed supplement will expand on parent grant examined the association between prenatal exposure to stress and resilience related to cultural factors and depressive symptoms during pregnancy on risk and presence of mood dysregulation via measures of physiological stress vulnerability, emotional reactivity and depressive symptoms in preschool children aged 3-5 years old. The supplement will investigate the role of cultural risk and resilience factors and built environmental variables on maternal depressive symptoms. The information obtained from the proposed research will aid in identifying modifiable factors aimed at treatment of those at risk for mental health disorders among the Mexican-American population.